Core C: Medicinal Chemistry and DMPK

Core C – Medicinal Chemistry and DMPK
ABSTRACT
The discovery of possible drug candidates requires effective collaboration of diverse teams of skilled scientists.
Medicinal chemists fulfill a core problem solving role, generally leading efforts to overcome the myriad of
obstacles sure to be encountered in any drug discovery campaign. A great many of these hurdles typically involve
overcoming deficiencies in drug metabolism and pharmacokinetic (DMPK) properties. Core C of the Midwest
AViDD Center centralizes medicinal chemistry and DMPK support functions, with a key role for computational
chemistry in impacting hit-to-lead efforts. Core C is comprised of top researchers in their fields, located at 8
different research sites: Scripps-FL, U. Minnesota, Georgia State U, U. Illinois-Chicago, U. Mississippi, N.Y.
Blood Center, U.C San Diego, and U.C. Berkeley. The effort seeks not to merely validate new targets and
discover “probes” that are ill-suited for development but is focused on the delivery of agents with high
translational potential. This philosophy derives in part from the extensive industrial experience of many key
personnel in the core. Objectives include the identification and triage of validated hit series, their optimization to
validated leads, and finally to the delivery of tractable orally bioavailable drug development candidates in multiple
target areas for viruses with high pandemic potential.

Public health relevance
Core C – Medicinal Chemistry and DMPK NARRATIVE Any effort focused on the delivery of agents with high translational potential must carefully consider strategies to overcome deficiencies in screening hits, lead molecules, and development candidates. Core C of the Midwest AViDD Center centralizes medicinal chemistry, DMPK, and computational hit-to-lead support functions. The center’s core C resourcing decisions will be agile and responsive to opportunities and to emerging discoveries. We will adjust support, favoring projects showing the highest potential for success. There is a mixture of low- risk, moderate-risk, and higher-risk targets among the 5 projects, including approaches that might identify broad- spectrum agents. The assembled experts in Core C are appropriately focused on issues of druglikeness and maximizing the potential for success of orally bioavailable drug development candidates in multiple target areas for viruses with high pandemic potential.